Future Leaders Advancing Research in Endocrinology (FLARE): Professional Development for Underrepresented Trainees and Junior Faculty

ABSTRACT
Recruitment, training, and retention of a diverse biomedical and clinical workforce is an essential component of
any comprehensive approach aimed at advancing health and health equity. Importantly, while several
organizations, including professional societies, develop trainee-focused programs, relatively few focus on the
unique needs of minorities underrepresented in life sciences, specifically in biomedical and clinical research
particularly throughout critical career transitions. To meet this need, the Endocrine Society developed the
Future Leaders Advancing Research in Endocrinology (FLARE) Program, a multi-faceted training program
for minority graduate students, postdoctoral fellows, clinical fellows, and early-stage faculty involved in
endocrine-related research. The objective of the program is to actively foster the professional development of
these early-stage investigators to enhance their preparedness for career advancement within research-based
institutions, the scientific community at large and to develop them as future leaders of the Endocrine Society
itself. Program components include a leadership training workshop, a virtual community, a mentoring program
to build relationships between FLARE fellows and dedicated mentors, a Society-based internship, and a
fellow/alumni symposium. Fellows selected for the internship participate in a governance committee of the
Society and develop mentoring skills by engaging with undergraduate students participating in the Society’s
summer research fellowship program and by visiting minority serving institutions to give seminars and host
mentoring workshops. The FLARE Program also collaborates with other established diversity, inclusion, and
outreach initiatives such as the Keystone Symposia Fellows Program, and the Network of Minority Research
Investigators of the NIDDK, that provide additional opportunities for networking and career advancement in
addition to identifying mentors and new FLARE faculty. Thus, the FLARE Program provides early career
minority investigators with unique and targeted professional development and enhancement opportunities that
prepare them to succeed and emerge as leaders in biomedical and clinical research careers.

Public health relevance
PROJECT NARRATIVE Chronic, endocrine disorders such as diabetes, disproportionately impact racial and ethnic minority communities, yet these same populations are grossly underrepresented among the professionals that study and treat these prevalent conditions. Professional development efforts such as the Future Leaders Advancing Research in Endocrinology (FLARE) Program will enhance the recruitment and retention of minority trainees within the biomedical and clinical workforce and prepare them to advance as productive leaders within the scientific community. A strong mentorship component to the Program aims to further decrease health disparities by allowing these individuals to become inspirational role models for future generations of diverse biomedical and clinical professionals.